Molecular Transducers of Physical Activity and Health: NC Consortium Clinical Site

ABSTRACT
Exercise is a powerful physiological stimulus contributing to disease prevention and intervention. The
protective and preventive effects of exercise are well-documented for metabolic, neurodegenerative, and
cardiovascular diseases, and certain cancers. While scientists acknowledge the extensive benefits of
exercise, there is still insufficient understanding about the underlying mechanisms by which exercise prevents
disease and improves health across diverse organ systems. The NIH Common Fund has developed a
forward-looking funding mechanism — six tethered RFA's tied to creating a research consortium, the Molecular
Transducers of Physical Activity Consortium (MoTrPAC) — to create resources and critical information for
exercise and health investigators well into the future. Two products of the MoTrPAC collective efforts will be a
publically available data resource that will enhance and accelerate subsequent mechanistic research on
diseases and conditions affected by physical activity; and a biorepository of clinical and animal model samples
to be used in studying exercise biology. Based on prior collaborative efforts, our group believes that we are
ideally positioned to propose a protocol that will respond directly to the RFA, while at the same time execute
the large volume of tests to complete the ~450 people required at each site within the MoTrPAC consortium.
To accomplish all of our Clinical Center goals, we have developed a consortium — the North Carolina Clinical
Site Consortium (NCCSC). The NCCSC consists of the experienced research teams Duke University School
of Medicine; East Carolina University (ECU); and Wake Forest School of Medicine (WFSM). As described in
the study plan, the NCCSC weighed a number of alternatives for training regimens, timing, and type of tissue
sampling, sample sizes for the four obligated study groups, and other factors, while staying within budget
constraints. The following Aims will maximize the value of the data and sample repositories; this will be
accomplished with the enrollment of 540 individuals and finishing 450.
· Aim 1: To determine the response of molecular transducers to a single acute bout of either aerobic or
resistance training.
· Aim 2: To determine the responses of molecular transducers to a chronic exercise training program of
either aerobic or resistance training.
· Aim 3: To determine the responses of molecular transducers to a detraining period following either aerobic
or resistance training.

Public health relevance
RESEARCH NARRATIVE Exercise is a powerful physiological stimulus contributing to disease prevention and intervention. The protective effects of exercise are well-documented for metabolic, neurodegenerative, and cardiovascular diseases and certain cancers. While scientists acknowledge the extensive benefits of exercise, there is still insufficient understanding about the underlying mechanisms by which exercise prevents disease and improves health across diverse organ systems. This project will contribute to a larger NIH-funded effort to develop resources for the work of present and future investigators working in this area.